NCI BUDGET SOLUTION AND BUSINESS INTELLIGENCE ASSESSMENT

Funding this contract option continues the investment started previously involving identifying the requirements and making changes to modernize the processes and IT systems used by OSO in planning, executing and reporting the NCI funding.